EX VIVO MARROW TREATMENT FOR MHC MATCHED AND MISMATCHED BMT PATIENTS

This is a phase I/II study of the use of a anti-CD5 monoclonal antibody (ST-1) conjugated to the a chain of ricin to deplete T cells from marrow prior to marrow transplantation.